MEDICAL WRITING CONSULTING AND DRUG DOSSIER DEVELOPMENT SUPPORT SERVICES

MEDICAL WRITING CONSULTING AND DRUG DOSSIER DEVELOPMENT SUPPORT SERVICES- NIH HEAL Initiative-

“This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”

Public health relevance
“This study is part of the NIH’s Helping to End Addiction Long-term (HEAL) initiative to speed scientific solutions to understand the basis of pain and enhance clinical pain management.”